Genetic analysis of the Robo3+ glycinergic amacrine cell

Project Summary
The retina is an excellent model for studying the development and function of neural circuitry. The
retina contains five major neuronal classes which can be subdivided into well over a hundred neuronal
subtypes. Amacrine Cells (ACs), one of the five neuronal classes, comprise only one percent of the retinal cell
population, but account for around half of this subtype diversity. Only a handful of AC subtypes have been
studied in depth, in part due to a lack of tools to prospectively isolate and manipulate individual populations.
Therefore, our understanding of how visual circuits function remains incomplete. For example, recent work
shows that the direction selective circuit, one of the most well-studied circuits in the retina, includes glycinergic
input from an undefined AC subtype. To fully understand how ACs contribute to visual processing it is
imperative to study more AC subtypes and their defining features.
In preliminary studies, I identified a Robo3CreER mouse line that genetically labels a population of
previously undescribed glycinergic amacrine cells. Based on their morphology and stratification pattern, I
hypothesize that these Robo3+ amacrine cells (RACs) may be the cells that supply glycinergic inhibition to ON
starburst amacrine cells in the direction selective circuit. I will employ mouse genetics, confocal microscopy, in
situ hybridization, electron microscopy, and electrophysiology to test this hypothesis. In Aim 1, I will define the
morphological properties and population-level organization of RACs. In Aim 2, I will determine whether RACs
form inhibitory synapses onto ON starburst amacrine cells. In Aim 3, I will determine whether Robo3 plays a
role in RAC development and/or function. These aims will broaden our knowledge of how individual cellular
components function together in retinal circuitry.

Public health relevance
Project Narrative The retina is an excellent model system for studying the function of specific neuronal subtypes within a circuit. This proposal uses a genetic approach to target a previously uncharacterized population of glycinergic amacrine cells to define their morphological properties and to test the hypothesis that this population provides inhibitory input to the direction selective circuit. It will also test whether the selective expression of Robo3 in this population is required for their proper development.